Innovative Tools for Chemical Synthesis: Cyclase-Inspired Catalysis, Shuttle Catalysis, and Tandem Catalysis

Principle Investigator/Program Director (Last, first, middle): Dong, Vy, M Project Summary/Abstract: The synthesis and implementation of organometallic reagents and intermediates has become a cornerstone in the formation of complex therapeutic agents. Thus, the development of novel methods for accessing these intermediates in a simple and efficient manner has become a large focus of the synthetic organic and organometallic community. Organozinc reagents have shown themselves to be a powerful tool in complex organic synthesis in areas such as carbonyl addition, cross coupling reactions (Negeshi coupling), and functionalization of alkenes and alkynes. As the need for these important nucleophiles becomes more apparent, chemists have sought out ways to make them by efficient and sustainable methods. Previous work by Knochel and Sato has shown that nickel and titanium catalysts can convert olefins to organozincs efficiently, however their work does not impose stereochemical selectivity. Our goal, described herein, is to expand on the use of titanium catalysis to generate organozincs in an enantiopure method using chiral titanium catalysts and simple, unbiased olefins as starting materials. Following the formation of these stereochemically active nucleophiles, we aim to couple them with carbon dioxide using chemistry similar to previous studies in the Dong research group. Utilizing simple and readily available starting materials as well as more structurally diverse catalysts and substrates to gain access to these species could improve access to organozinc intermediates as well as their use in the synthesis of complex final products.

Public health relevance
Principle Investigator/Program Director (Last, first, middle): Dong, Vy, M Project Narrative: Organozinc compounds have found themselves to be key parts of the organic chemist’s synthetic toolbox in their use in the functionalization of complex natural products and therapeutic targets. Even with the continued growth of their presence in synthetic chemistry, formation of organozinc reagents typically start from expensive organohalides or with little to no stereochemical selectivity. We aim to merge our advancements in transition metal catalysis to develop new methods for the formation of these important species in an enantiopure way using chiral catalysts to activate cheap and readily available substrates.